ENERGY CONVERSION IN BIOLOGY

A large number of different topics have been studied in the general field of free energy transduction. The most important areas in which progress has been made are the study of oscillations in microtubule growth dynamics, the role of kinesin in fast axonal transport, free energy transduction by random fluctuations, proton pumping in oxidative phosphorylation, kinetic schemes for DNA gyrase, and cooperativity in cytochrome oxidase.